Project 3 - Genome-Guided Therapeutic Vulnerabilities in Esophageal Cancer

PROJECT SUMMARY – PROJECT 3
New therapies are desperately needed for esophageal cancer, which is responsible for >400,000 deaths
annually. Herein we propose to build on momentum from our prior studies, founded on our observation that
the most prominent genomic targets in esophageal cancer, both squamous cell carcinoma (ESSC) and
adenocarcinoma (EAC), are amplifications of genes encoding mediators of the cell cycle such as
CCND1=Cyclin D1 (collaboration with Project 3) and CCNE1=Cyclin E1 and genes encoding receptor tyrosine
kinases such as EGFR (collaboration with Project 1) and ERBB2. Given this genomic landscape, a key
premise of our work has been that developing therapeutic approaches that integrate targeting of both active
kinases and cell cycle dysregulation will be remarkably beneficial. While these data, hypotheses and premises
all continue to hold true, we now propose a more nuanced assessment of how cell cycle dysregulation may
impact tumorigenesis and optimal cancer therapy. Specifically, we hypothesize that amplification and
overexpression of Cyclin D1 and Cyclin E1 can have effects upon the tumor microenvironment and upon
genomic stability, both of which have clear implications for optimal therapy. This hypothesis will be pursued
through the following interrelated Specific Aims: (1) To determine how CDK4/6 inhibitors impact the tumor
microenvironment in CCND1-amplified esophageal squamous cell carcinoma and to define enhanced immune
therapy strategies; and (2) To elucidate how CCNE1 amplification promotes chromosomal instability, kinase
amplification and immune evasion in esophageal adenocarcinoma. Together, these studies will help us
develop rationale, biomarker-guided therapies for these deadly cancers. This work will be done in close
collaboration with Projects 1 and 2 to drive presentations, publications and transform the clinical landscape of
esophageal cancer, and to utilize the core facilities in an integrated fashion with the other Projects.

Public health relevance
PROJECT NARRATIVE – PROJECT 3 New therapies are desperately needed for esophageal cancer, which is responsible for >400,000 deaths annually. In this project, we focus on the role of key cell cycle mediators that we propose both promote cancer and enhance immune evasion by the tumor. We will investigate specific strategies to target key cell cycle oncogenes, evaluating both their effects on cell-autonomous features of these cancers and upon the anti-tumor immune response.